Women's Reproductive Health Research at the University of Washington

PROJECT SUMMARY/ABSTRACT
The Women's Reproductive Health Research (WRHR) program, an early career development program for
obstetrician gynecologists, was established at the University of Washington (UW) in 1998. The aim of the UW
WRHR program is to foster the education, training and scientific development of obstetrician gynecologists
who demonstrate clear research potential and who are committed to a career in academic medicine. Our long-
term goal is to improve women's health. The program has successfully trained 11 individuals, with 2 scholars
currently in training.
This proposal describes a plan for continuation of the UW WRHR program. The goal remains a commitment to
bridge the gap between clinical and research training to enable young physicians to establish research careers
tailored to their specific interests and to become independent scientific investigators. Proposed training is a
multidisciplinary mentored experience for 2-5 years with 2 positions available per year. During this period, a
scholar devotes at least 75% of his/her time to research. The program aims to recruit individuals from other
institutions and to recruit individuals from under-represented backgrounds.
The UW WRHR is unique in encouraging cross disciplinary research and is designed to provide training
environments that create the best opportunities for scholars. We have a distinguished group of 23 mentors with
expertise in a diverse spectrum of specialties ranging from genomics to global health — with investigation in
obstetrics, gynecology, and women's reproductive health research as the core activity. Particular strengths
include: reproductive immunology, infectious disease, genetics, molecular biology, disease prevention, health
care disparities, prematurity and global health. We believe that through partnerships with outstanding scientists
in disciplines that lie outside of the traditional boundaries of obstetrics and gynecology, our scholars have the
greatest opportunity to achieve their scientific potential, build unique and successful interdisciplinary careers,
and advance the cause to improve the health and well-being of women and their families. The Obstetrics &
Gynecology Department and the School of Medicine at UW are prepared to make major commitments to
support continuation of the UW WRHR program in order to positively impact the health of women around the
globe.

Public health relevance
PROJECT NARRATIVE The UW Women's Reproductive Health Research (WRHR) Program plans to promote diversity in the approach, and originality in the execution of our career development program. The novel multidisciplinary methods proposed to train early career obstetrician gynecologist scientists are most apt to be successful in answering questions of greatest merit, with maximum possibility of impacting the health of all women.